Transcription and Splicing Dynamics in Single Cells

Gene Expression in Single Cells: Gene expression refers to the sum of processes that enable cells to control their complement of RNA and protein. Megadalton molecular machines such as RNA polymerase, the spliceosome, and the ribosome carry out the synthesis, processing, and translation of RNA. Advances in structural biology have revealed the atomic details of these machines, and the revolution in sequencing has engendered an understanding of their respective enzymatic activities with nucleotide resolution. A central challenge in cell biology is to understand how these processes are coupled and regulated in time and space in single living cells. In recent years, through parallel advances in microscopy, fluorescent probe development, computational modeling, and gene editing it is now possible to directly observe the processes of gene expression (transcription, splicing, translation) in living cells. The Larson lab has played an essential role in this development, for example by being the first lab to visualize transcription and splicing of single human genes in real time. The view that has emerged from these studies is that gene regulation is an extremely dynamic process where the random behavior of individual molecules plays an important role in determining how a cell controls expression. Coupling live-cell imaging with RNA-sequencing based methods is an exciting approach for understanding gene expression in health and disease. Gene Expression in Myeloid Malignancy: The differentiation of hematopoietic stem cells into committed lineages in the blood is the result of concerted regulation between transcription, splicing and translation, and a goal of the laboratory is to understand the dynamic interplay between these processes in single cells. Moreover, mutations in the gene expression machinery drive the development of clonal stem cell disorders termed 'myeloid malignancies.' Specifically, the Myelodysplastic Syndromes (MDS) and Acute Myeloid Leukemia (AML) are a heterogeneous group of malignant clonal hematopoietic stem cell disorders with poor prognosis and few treatment options. MDS is characterized by ineffective hematopoiesis, marrow dysplasia, peripheral blood cytopenia, and a high propensity for transformation into AML, which is an acute proliferative disease. Simply stated, MDS is a disease of differentiation, while AML is a disease of differentiation plus proliferation. Over 60% of MDS patients carry a mutation in the spliceosome, and the Larson lab has proposed a non-canonical role for the splicing machinery in disease progression. Overall, gene regulation in this tissue is exceptionally dependent on post-transcriptional mechanisms, opening new avenues of research for understanding hematopoiesis. Analysis of primary human samples and close coupling with the newly-established Myeloid Malignancies clinical program - "bench-to-bedside-to-bench" - makes this area a vibrant and impactful area of study where basic concepts in gene regulation can be immediately applied to human health. Thus, the projects in the laboratory are loosely divided into several areas: 1) Visualizing spliceosome assembly and splice site selection 2) Deciphering the role of nuclear structure in modulating gene expression 3) Determining the causes and consequences of transcriptional heterogeneity 4) Developing in vitro reconstituted models for examining the coupling between transcription, splicing, translation 5) Computational analysis of gene expression 6) Understanding gene expression alteration in myeloid malignancy.